Diffusion Basis Spectrum Imaging for Measurement of Neuroinflammation in Parkinson Disease

Project Summary/Abstract
Parkinson disease (PD) is an age-related neurodegenerative disease affecting a large number of U.S. veterans
that causes significant motor symptoms such as slow movement and tremor, as well as non-motor symptoms
such as cognitive decline and dementia. Development of therapies to slow PD progression requires validated
biomarkers of pathologic processes that predict progression. The brain’s inflammatory response is increasingly
recognized as an important source of pathology in PD, and imaging biomarkers of neuroinflammation in PD are
needed. A novel Magnetic Resonance Imaging (MRI) technique, Diffusion Basis Spectrum Imaging (DBSI), is
sensitive to intermingled changes in brain microstructure, and has the capacity to measure the component of
inflammatory cells within a volume of tissue, and distinguish this component from neurodegenerative pathology
or anatomic variation. DBSI MRI has been recently shown to quantify neuroinflammation in multiple sclerosis
and Alzheimer’s disease. Here, we will develop and validate this measure in PD. We will determine how the
DBSI measure of neuroinflammation compares to quantitative immunohistochemistry in already-collected
antemortem MRI data with corresponding postmortem fixed brain tissues from people with PD (Aim 1).
Prospectively, in PD and control participants we will compare DBSI measures to the positron emission
tomography (PET) marker of neuroinflammation, PBR28 (Aim 2), and to the activation profile of T cells in blood
and cerebrospinal fluid (Aim 3). We will correlate cross-sectional and longitudinal DBSI measures with clinical
features of motor and cognitive disease progression (Aim 4). In this manner, we will develop a strong
mechanistic understanding of changes in both neuroimaging and T cell biomarkers of inflammation, and how
these relate to motor and cognitive decline in PD. This project holds great promise for identifying and validating
biomarkers of neuroinflammation for prediction of PD progression, patient stratification for trials, and evaluation
of new treatments targeting the immune system in PD. Because DBSI MRI only requires sequences that are
already Food and Drug Administration approved and available on existing clinical MRI scanners, it could be
quickly scaled to clinical applications and clinical trials.

Public health relevance
Project Narrative Parkinson disease (PD) is a progressive neurological disorder strongly linked to advancing age that ultimately results in decline in mobility and thinking. Approximately 100,000 veterans with PD receive care from the Department of Veterans Affairs, and this number is expected to grow in the coming decades. Inflammation in the brain may play an important role in the progression of these impairments, but we lack easily accessible tools to identify and measure inflammation in the brain. The main goal of this project is to use a novel brain imaging test, diffusion basis spectrum imaging (DBSI), to examine brain inflammation in veterans with PD. We will compare DBSI to other measures of inflammation and use it to predict clinical progression in PD. This will help us understand the role of inflammation in PD and lead to development of a readily-available, noninvasive brain imaging measure of inflammation, which will be useful in clinical trials of agents that target the immune system.